Seen and mental images in visual cortex

ABSTRACT
The long term goal of our research is to understand the computational role of mental imagery in
human cognition, and to operationalize this understanding to provide new tools for improving
mental health. For most people, mental imagery is experienced as visual content that is
independent of vision but indispensable for thought. This experience suggests that mental
imagery serves an important cognitive function; however, studies of the brain systems that
generate mental imagery have yet to reveal how or if mental images contribute to cognition. In
this proposal, we test the hypothesis that mental imagery supports cognition by permitting the
comparison of seen to unseen images. The comparison of seen and unseen images is a routine
operation that occurs, for example, when one judges how a seen image differs from a
remembered image, or from a target image that one wants to detect. To test this hypothesis we
will measure brain activity in people as they imagine and as they complete a variety of tasks that
require them to compare pictures displayed on a screen to pictures that they have been asked
to remember. Using techniques borrowed from artificial intelligence (AI) we will extract from
these data information about individual mental images, and then determine if this information
can predict brain activity and behavior during the tasks. If successful, this proposal will establish
a functional and computational role for imagery. Since very little is currently known about the
function of mental imagery, our work is an essential step toward understanding how mental
imagery interacts with and supports cognition, and how disregulated mental imagery can disrupt
mental health.

Public health relevance
PUBLIC HEALTH RELEVANCE The generation of mental imagery is believed to be critical for cognition and mental health. This proposal will investigate the brain systems responsible for generating mental images and the role that mental images play in performing essential cognitive tasks.